The Robert T. Malison Yale-Chulalongkorn Stress, Alcohol Use and Psychopathology Training Program

Abstract
Psychiatric disorders are a set of chronic, non-communicable diseases (NCDs), a global public health problem
of enormous economic, social, and medical cost to the international community. Stress, alcohol use and other
factors (social and environmental; physical disorders) often exacerbate psychiatric disorders. Low and middle
income and developing countries are disproportionately affected due to both economic disadvantages and the
less well-established institutional infrastructures dedicated to the understanding, treatment and prevention of
psychopathology. We propose a collaborative research training program in the multidisciplinary, translational
research of stress, alcohol use and psychopathology between Faculty of Medicine, Chulalongkorn University in
Bangkok, Thailand (the lead Thai site) Phramongkutklao (PMK) Hospital, also in Bangkok, and Prince of Songkla
University (PSU) in Hat Yai, Thailand; and the Yale University School of Medicine in the U.S. The project is
directed by leaders in Thailand and the US, Dr. Kalayasiri at Chulalongkorn, and Drs. Potenza and Gelernter at
Yale, mPIs for this application. Three major training mechanisms are proposed for Thai trainees, including long-
term (1-2-yr) predoctoral and postdoctoral fellowships, and short-term (1-6 month) fellowships. During the five-
year program, training responsibility increases at Chulalongkorn, PMK, and PSU (as experience builds) and
decreases at Yale. This program builds on an extensive research program in Psychiatry at Yale University School
of Medicine, and on existing training and research collaborations between investigators at Yale and investigators
at Chulalongkorn in the study of the genetics and clinical correlates of psychopathology (especially substance
use disorders) in Thai populations. The program will contribute to the capacity of investigators at Chulalongkorn,
PMK and PSU and more generally in Thailand to conduct state-of-the-art research in interdisciplinary and
translational research in psychiatry through a range of training experiences (genetics, molecular biology, clinical,
developmental, psychopharmacology, clinical trials, neuroimaging, implementation, community, and policy
research); and has strong ongoing potential for clinical translation. The explicit long-term goal of the program will
be to build a critical mass of scientists, health professionals, and academics with expertise and a sustainable
research environment at the collaborating Thai institutions to better understand, treat, and prevent the NCDs of
psychiatric illnesses. This training program is also specifically designed to serve a major public health purpose
by enhancing Thailand’s capacity to confront major health concerns including alcohol and other stress-related
disorders that are unprecedented in Thailand’s history. The context of this program is a long-term research and
training collaboration between Yale and Chulalongkorn that focused on drug dependence which was co-led by
at Yale by Drs. Gelernter and Malison. This new program with a new focus is expanded in scope to address the
needs of Thailand better and include a Thai mPI, and is now named “The Robert T. Malison Yale-Chulalongkorn
Stress, Alcohol Use and Psychopathology Training Program” for Dr. Malison, who passed in July, 2020.

Public health relevance
Narrative Psychiatric disorders, including alcohol use disorder and other stress-related disorders (e.g., post-traumatic stress disorder, major depressive disorder and others), are a set of chronic, non-communicable diseases (NCDs) that constitute a global public health problem of enormous economic, social, and medical cost internationally. Low and middle-income and developing countries such as Thailand are disproportionately affected due to both unique stressors experienced and less well-established institutional infrastructures (facilities, personnel, and research) dedicated to the understanding, treatment and prevention of psychiatric disorders; especially so during the COVID-19 pandemic when many countries, including Thailand, experienced extensive shutdowns and an interruption of the tourist industry, a major source of income. In the current application, we propose a collaborative research training program in the interdisciplinary and translational research of stress, alcohol use and psychopathology between three Thai institutes (the Chulalongkorn University Faculty of Medicine (a leading medical research center in Thailand and established collaborator, the lead Thai site), Phramongkutklao Hospital and Medical College in Bangkok, Thailand (a new collaborator), and Prince of Songkla University in Hat Yai, Thailand (also a new collaborator)) and the Yale University School of Medicine in the U.S.